Mitochondrial inner membrane architecture in skeletal muscle pathophysiology

Project Summary
Muscle is a contractile tissue that generates forces and motions vital for animal survival. The molecular and cellular
mechanisms governing its structural and functional integrity are not well understood. Selective dysfunction and
degeneration of neuromuscular tissues have been observed in disease conditions featuring mitochondrial
abnormality, emphasizing the particular importance of mitochondria to the functionality and integrity of muscle
tissues. Mitochondria play important roles in cellular bioenergetics as well as other essential aspects of cellular
physiology. The mitochondrial processes that are essential for the structural and functional integrity of skeletal
muscle, and how these processes are regulated in health and disease are poorly defined. It is becoming
increasingly clear that fundamental mechanisms underlying the development, function, and maintenance of skeletal
muscle are conserved across metazoans. Thus genetic model organisms are poised to make significant
contributions to our understanding of these mechanisms. In our previous studies, we have used Drosophila as a
model to demonstrate the importance of Numb/Notch signaling and asymmetric progenitor cell division during
muscle development, and PINK1/Parkin-directed mitochondrial quality control in skeletal muscle maintenance. We
have also used the fly neuromuscular junction (NMJ) as a model to dissect synaptic mechanisms involved in age-
related neurodegenerative diseases. In our most recent studies, we have found that protein quality control in the
mitochondrial intermembrane space (IMS) is important for skeletal muscle function and maintenance. We found that
dipeptide repeats (DPRs) derived from unconventional translation of the GGGGCC (G4C2) hexanucleotide repeat
expansion in C9ORF72, the most common genetic cause of amyotrophic lateral sclerosis (ALS) called c9ALS,
disrupt mitochondrial function by altering IMS proteostasis and inner membrane (IM) architecture. Our genetic
modifier screens identified a number of signaling pathways in mitigating this ALS-related muscle pathology. The goal
of this proposal is to use proteomic, molecular genetic, and cell biological tools to define the mechanism of action of
the identified genetic pathways, in an effort to achieve a holistic view of the regulation and function of mitochondrial
IM architecture in skeletal muscle function and maintenance. Two Specific Aims will help us reach this goal. In Aim
1, we will examine the molecular mechanisms of how c9ALS disease gene product disrupts muscle mitochondrial
IMS/IM structure and function. Novel genetic tools will be used to perform ultrastructural studies and find the
interactome of DPR within these structures. In Aim 2, we will delineate the cellular quality control mechanisms that
maintain IMS/IM integrity by restraining the synthesis or promoting the metabolism of DPR. The role of these quality
control mechanisms in maintaining mitochondrial and skeletal muscle structure and function during normal aging will
also be examined. These studies will significantly advance our understanding of the role of mitochondria in
maintaining skeletal muscle structure and function. Results from this study promise to inform the development of
novel and rational muscle-targeting medicine for ALS and conditions such as sarcopenia.

Public health relevance
Project Narrative Compared to muscle development, we know less about how the structural and functional integrity of muscle is maintained. The goal of this project is to define at the molecular terms the importance of mitochondria to the functionality and integrity of muscle tissues, in an effort to provide insight into the pathogenesis of mitochondria-related muscular disease and the progressive loss of skeletal muscle function and mass known as sarcopenia, and suggest novel therapeutic avenues.